The Critical Role of Ciliary ARL13B in Controlling Energy Homeostasis

PROJECT SUMMARY: Obesity is a growing public health crisis associated with life-threatening comorbidities
such as hypertension, type 2 diabetes, and coronary heart disease. More than two-thirds of Americans are
overweight or obese, and one-sixth of children are obese. The economic impact associated with obesity is
substantial, costing approximately $300 billion annually in medical costs. Obesity is a complex disease involving
environmental, psychological, metabolic, and genetic factors. A class of genetic disorders that present with
severe obesity are ciliopathies due to disruptions to the cilia or ciliary genes. Mouse models of neuronal cilia
dysfunction cause hyperphagia-associated obesity as hunger and satiety signals that control feeding behavior
are regulated by neurons in the hypothalamus. Multiple G-protein coupled receptors (GPCRs) highly enriched in
neuronal cilia and involved in regulating energy homeostasis mislocalize in human and animal models of cilia-
associated obesity, indicating a critical role for ciliary signaling in the hypothalamic control of feeding behavior.
Understanding how ciliary signaling is involved in regulating feeding behavior and energy balance is integral to
developing new treatment strategies. Cilia, small microtubule projections emanating from almost every cell, are
critical signaling centers. Delineating ciliary signaling pathways in vivo is especially challenging with current
genetic models as loss of cilia ablates all ciliary signaling, while genetic deletion of ciliary proteins removes both
ciliary and cellular protein. Our lab genetically engineered a cilia-excluded mutant mouse, Arl13bV358A, where the
ARL13BV358A protein is excluded from the cilia but retains all its known functions. ARL13B is a regulatory GTPase
highly enriched in cilia and known for its role in ciliogenesis. Arl13bV358A/V358A mice are viable and fertile; they are
also hyperphagic and obese and display defects in glucose and insulin metabolism. Our findings identify that
ARL13B’s function within the cilia controls normal feeding behavior and that our cilia-excluded mouse model is
well suited to isolate ARL13B’s ciliary role in obesity. The long-term goal of this proposal is to dissect the cilia-
specific function of ARL13B as a regulator of energy homeostasis. I will test my central hypothesis that ciliary
ARL13B is required to regulate energy homeostasis. In Aim 1, I will determine the impact of ciliary ARL13B in
specific neuronal populations in regulating energy homeostasis. In Aim 2, I will test whether ciliary ARL13B in
the same neuronal populations is sufficient to regulate energy homeostasis. In Aim 3, I will investigate whether
ciliary ARL13B is continuously required by introducing ciliary ARL13B before and after the obesity phenotype.
Successful completion of these aims will (1) determine the ciliary contribution of ARL13B in specific neuronal
populations to regulate energy homeostasis and (2) delineate to what extent ciliary ARL13B can rescue and
reverse the obesity phenotype.

Public health relevance
PROJECT NARRATIVE Disruption to the cilia, a small cell protrusion, in the feeding center of the brain causes obesity. In this research proposal, I will define how a ciliary GTPase regulates feeding behavior. A better understanding of satiety and appetite control will enable new strategies to combat obesity, a major public health concern.